Studies on Protein Lipidation

DESCRIPTION (provided by applicant): Dynamic S-palmitoylation of proteins controls a variety of key signaling pathways in eukaryotes that are not well understood. Our laboratory has recently developed robust chemical tools to rapidly analyze dynamic S-palmitoylation of proteins and identify S-palmitoylated proteins on large-scale. The grant application describes that application of our chemical tools to fission yeast in order to dissect the mechanisms that regulated S-palmitoylation. Our preliminary studies have revealed defects in S-palmitoylation that influence whether fission yeast cells divide (mitosis) or differentiate (meiosis). These preliminary data are very exciting as it begins to identify molecular mechanisms that eukaryotic cells use to control decision-making and cell fate and highlights the utility of Sz. pombe for mechanistic studies in S-palmitoylation. The detailed analysis of dynamic S-palmitoylation proposed in this grant is therefore essential for understanding the basic mechanisms of cell signaling and is important for dissecting the defects in protein S-palmitoylation associated with human diseases such as cancer and neurological disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal describes the development and application of chemical tools to fission yeast to understand fundamental mechanisms that regulate protein S-palmitoylation. These studies should reveal new pathways modulated by S-palmitoylation that are not well understood and provide important molecular insight into diseases linked to aberrant protein S-palmitoylation such as cancer and neurological disorders. PROJECT NARRATIVE This proposal describes the development and application of chemical tools to fission yeast to understand fundamental mechanisms that regulate protein S-palmitoylation. These studies should reveal new pathways modulated by S-palmitoylation that are not well understood and provide important molecular insight into diseases linked to aberrant protein S-palmitoylation such as cancer and neurological disorders. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Protein S-palmitoylation (S-acylation) is a dynamic post-translational modification that controls protein trafficking and signaling properties in many aspects of physiology, ranging from cell growth and differentiation to leukocyte activation and synaptic transmission in neurons. Misregulation of protein S-palmitoylation is associated with a variety of diseases including cancer and several neurological disorders such as schizophrenia and X-linked retardation. Functional analysis of protein S-palmitoylation in physiology and disease has been challenging due to complex regulatory mechanisms that control dynamic protein S- palmitoylation as well as limited methods for visualizing and identifying S-palmitoylated proteins. This proposal focuses on the development and application of chemical tools to characterize dynamic protein S-palmitoylation. Given the complexity of protein S-palmitoylation, we have turned to fission yeast, Schizosaccharomyces pombe - a genetically tractable model organism for eukaryotic cell biology - to investigate the functions of the protein S-acyltransferases that catalyze the S-palmitoylation of proteins. Our preliminary studies have already identified defects in cell viability and differentiation in fission yeast protein S- acyltransferase mutants not apparent in other eukaryotic systems, including budding yeast. To understand the function(s) of protein S-palmitoylation in eukaryotic cell biology, we will focus on a key protein S- acyltransferase - Erf2. Aim 1 of the proposal will investigate the phenotypes of Erf2 mutants in fission yeast. To dissect the mechanisms by which erf2Δ fission yeast strains are impaired in sexual differentiation - meiosis, we will evaluate S-palmitoylation, localization and activity of a prominent Erf2 substrate (Ras1) during meiosis in Aim 2. We will also evaluate other substrates of Erf2 that may contribute to defects in cellular differentiation using candidate-based approaches and fatty acid chemical reporters/proteomic methods in Aim 3. While S- acylation is dynamically controlled in cells, the cellular factors that control depalmitoylation are unknown. We will evaluate candidate thioesterase(s) responsible for dynamic S-acylation in Aim 4. The development and application of our chemical tools to fission yeast provides unique opportunities to characterize the mechanisms that regulate dynamic S-palmitoylation of proteins. These studies should reveal how S-palmitoylation of proteins coordinates complex signaling networks that enable eukaryotic cells to control cell fate decisions such as meiosis as well as reveal key enzymes that control depalmitoylation. The detailed functional analysis of dynamic S-palmitoylation is not specific to fission yeast physiology, but crucial for understanding the fundamental mechanisms that control cell signaling in eukaryotes. Given that S-palmitoylated proteins are often mutated many cancers and genetic lesions in protein S-acyltransferases can give rise to neurological disorders, dissecting the mechanisms that control dynamic S-palmitoylation is essential for understanding human physiology and disease. SUMMARY OF SPECIFIC AIMS Aim 1 - Investigate function(s) of Erf2 protein S-acyltransferase in fission yeast. Aim 1a - Analyze Erf2 protein S-acyltransferase mutants in meiosis. Aim 1b - Determine mating efficiency and cellular morphology of Erf2 mutants. Aim 2 - Analyze dynamic S-palmitoylation of Erf2 substrate during meoisis. Aim 2a - Evaluate dynamic S-palmitoylation of Erf2 substrate during meiosis. Aim 2b - Determine subcellular localization of Erf2 substrate during meiosis. Aim 2c - Investigate Erf2-regulated signaling pathways during meiosis. Aim 3 - Identify S-palmitoylated proteins expressed during meoisis. Aim 3a - Analyze additional Erf2 substrates in meiosis. Aim 3b - Identify S-palmitoylated proteins expressed during meiosis with chemical reporters. Aim 3c - Characterize meiosis-specific S-palmitoylated proteins. Aim 4 - Identify cellular factor(s) responsible for the depalmitoylation of proteins. Aim 4a - Analyze candidate thioesterase(s) responsible for depalmitoylation of proteins. Aim 4b. Characterize thioesterase(s) responsible for depalmitoylation of proteins.